Regulation of memory CD8 T cell development

PROJECT SUMMARY
Developing immunological memory is crucial for surviving deadly pandemics and while a better
understanding of how memory B and T cells form and function is being gained, there are still many gaps in
knowledge that limit our ability to create superior vaccines for several pathogens and new immunotherapies.
CD8+ T cells differentiate into heterogeneous subsets that display diverse functions, migration patterns and long-
term fates to protect against recurrent viral infection. How CD8+ T cells toggle between less-, intermediate- and
terminally-differentiated states remains a major question because this can influence the number and quality of
memory T cells that form. Great progress has been made in identifying transcription factors (TFs) and epigenetic
writers and erasers that control CD8+ T cell differentiation states, particularly the long-lived, multi-potent memory
precursor (MP) cells and shorter-lived, terminally-differentiated effector (TE) cells. But it is unclear what
determines which enhancers open and close to permit the targeting of these factors to specific loci that ultimately
creates the molecular foundation for a range of gene expression patterns and differentiation states in T cells. To
address this question, we are focusing on the nucleosome remodeling BRG1/BRM associated factor (BAF)
complexes because they sculpt the chromatin landscape by moving or evicting nucleosomes to control
accessibility of TFs and other chromatin modifiers.
There are three major BAF complexes (cBAF, ncBAF and PBAF), but BAF complexes lack intrinsic DNA-
binding specificity, and therefore how their chromatin remodeling activities are targeted within the genome
remains poorly understood. We hypothesize that lineage-specifying TFs target BAF complexes to discrete loci
in activated T cells, allowing BAF in turn, to make enhancers and promoters accessible for other TFs and
chromatin modifiers to regulate the spectrum of effector and memory CD8+ T cell fates that form during infection.
Our preliminary data show that cBAF is critical for the differentiation of TE cells in viral infection, demonstrating
that cBAF restricts CD8+ T cell plasticity and memory cell potential. This proposal aims to ‘map’ cBAF activity
across the genome to decode how it controls enhancer accessibility for specific TFs and other epigenetic
regulators such as CTCF and PRC2 in differentiating effector and memory CD8+ T cells. Conversely, we will
identify how certain TFs control cBAF recruitment to open-up sites that permit new differentiation states to arise.
This grant will also help us understand how nucleosome remodeling allows T cells to listen to certain signal
inputs while insulating themselves from others during infection to adopt specific differentiation states. Lastly, this
proposal will determine how the BAF complexes regulate the stability of or interconversion between T cell
differentiation states, and establish if cBAF, ncBAF and PBAF play cooperative or opposing functions in CD8+ T
cells. Broadly, the plasticity and rapid differentiation of CD8+ T cells responding to an infection in vivo offers an
unparalleled model for studying the biology of cell differentiation, lineage commitment, and reprogramming.

Public health relevance
PROJECT NARRATIVE Long-term immunity and the formation of protective memory B and T cells are necessary to survive deadly pandemics, as currently evidenced by COVID-19. Several transcriptional and epigenetic factors have been discovered that control the formation of diverse types of memory T cells, but we know very little about how these factors are targeted within the genome to control gene expression and specify T cell differentiation states. This proposal seeks to discover how BAF complexes, critical nucleosome remodelers, control the transcription factor networks that underlie effector and memory T cell development.